THE CHARACTERIZATION OF NATURAL MATERIALS AND METABOLIC PRODUCTS

NMR Studies have elucidated the structures of metabolites of the mold Alternaris alternans, alkaloids of the ant Chelaner antarcticus, synthetic fulgides, and the sodium bisulfite addition complex of phloroglucinol.